Rheumatoid Arthritis-associated Parenchymal Lung Disease: Clinical and Molecular Phenotypes

PROJECT SUMMARY / ABSTRACT
Rheumatoid arthritis (RA) is a systemic inflammatory disorder affecting approximately 1.5 million people in the
United States. Although parenchymal lung disease, which encompasses interstitial lung disease (ILD) and
emphysema, is a common lung complication of RA with increasing prevalence and mortality, no strategies
currently exist for early detection or risk stratification of progressive disease. This is an area of unmet need that
could lead to improved opportunities for intervention and a decrease in the considerable morbidity and
mortality of RA-associated parenchymal lung disease.
In this proposal, we aim to fully characterize early parenchymal lung disease in RA and establish risk
factors for progressive disease. We hypothesize that clinical and molecular risk factors can predict the
development and progression of RA-associated parenchymal lung disease, including preclinical ILD (preILD)
and emphysema, and that the molecular profile of progressive RA-preILD will overlap with fibrotic RA-ILD. To
test this hypothesis, we will propose the following: In Specific Aim 1, we will determine the prevalence and
progression of RA-associated preILD and emphysema using visual and objective radiologic approaches and
correlate these measurements with functional capacity, respiratory symptoms, and health-related quality of life
assessments. In Specific Aim 2, we will define clinical and molecular determinants that predict the
development and progression of RA emphysema and compare the molecular profile of emphysema with
preILD to provide mechanistic insight into the divergent patterns of parenchymal lung injury caused by RA. In
Specific Aim 3, we will demonstrate that progressive RA-preILD and fibrotic RA-ILD have similar molecular
signatures, suggesting phenotypic and mechanistic overlap. To achieve the aims of this proposal, a
longitudinal cohort of 200 RA patients without a history of ILD will be followed for up to 6 years with detailed
clinical, functional, radiologic, and molecular phenotyping.
The successful completion of this research will provide us with a better understanding of the early
characteristics and natural history of RA-associated ILD and emphysema and establish novel non-invasive
ways to identify those at risk for progressive disease. This will enable closer monitoring and earlier
opportunities for intervention, potentially leading to decreased morbidity and mortality in individuals afflicted
with RA-associated parenchymal lung disease.

Public health relevance
PROJECT NARRATIVE Rheumatoid arthritis (RA) is a systemic inflammatory disorder affecting approximately 1.5 million adults in the United States; parenchymal lung disease, which includes interstitial lung disease and emphysema, is a common lung complication of RA associated with significant morbidity and mortality. This study aims to better define clinical and molecular features of early RA-associated parenchymal lung disease, thereby leading to improved non-invasive ways to identify those at risk for progressive disease. The results of this work have the potential to lead to earlier opportunities for intervention and improved outcomes in RA patients with interstitial lung disease and emphysema.